Nitrosative Stress and Oral Bacteria

Summary
Nitrite and nitric oxide are widespread and robust signaling modulators that are emerging as
potential new antibacterial therapeutic agents. The oral cavity has particularly high concentrations
of nitrite, which can reach 1mM. Oral microorganisms have adapted to survive such high
nitrosative stress exposure and, we expect, that disruption of these adaptation mechanisms will
reduce growth and survival of bacteria in the oral environment. We know that Porphyromonas
gingivalis, a periodontopathogen, has high tolerance of nitrosative stress. However, the complex
signaling pathways setting the basis of this tolerance are yet to be determined in in this bacterium
as well as in other oral bacteria. Using whole genome expression analysis we have identified hcp
encoding newly re-designated S-nitrosylase as the most dramatically upregulated gene under
nitrosative stress. Furthermore, we demonstrated that regulation of Hcp is dependent on an FNR-
like regulator, HcpR, that employs novel hemin-dependent mechanism to sense nitrosative stress.
We hypothesize that the HcpR-Hcp system is central for adaptation of P. gingivalis to nitrosative
stress. Thus, we will first define the molecular mechanisms of P. gingivalis sensing nitrosative
stress through determination of the structural and biochemical characteristics of HcpR. Since
adaptation to nitrosative stress involves a novel enzymatic activity mediated by Hcp, we will
characterize the Hcp-mediated S-nitrosylome using proteomic approaches. In addition, we will
characterize the mechanism P. gingivalis Hcp employs to mediate protection against nitrosative
stress. Finally, we will investigate the contribution of other putative regulatory and effector
proteins in nitrosative stress defense in P. gingivalis. It is noteworthy, that we will verify the
contribution of the mechanisms under host-pathogen setting. This knowledge will provide the tools
to design agents that can compromise the defense mechanisms of the periodontopathogen and
turn endogenous human host nitrite and nitric oxide into a weapon that inhibits growth of the
bacterium and, ultimately, we can exploit it to treat periodontal disease. We predict that this work
will shed light on nitrosative stress signaling mechanisms in a variety of other bacteria that carry
similar nitrosative stress protection mechanisms to those in P. gingivalis.

Public health relevance
The high concentrations of nitrite in oral cavity as well as the nitric oxide released by inflamed periodontal tissues pose serious threat to survival of a periodontopathogen Porphyromonas gingivalis; therefore adaptation mechanisms to nitrosative stress are necessary for successful establishment and survival of the organism. So far our understanding of the adaptive and regulatory mechanisms governing this adaptation in P. gingivalis is rudimentary and the molecular, genetic, proteomic, structural and cellular approaches that I propose are expected to illuminate the mechanisms of Porphyromonas gingivalis adaptation to nitrosative stresses. This work is guided by the conviction that a cellular and molecular understanding of adaptation of P. gingivalis to nitrosative stress will give way to novel translational approaches for both treating and preventing adult periodontal disease.